Single Cell Dissection of Cerebrovascular Dysfunction in Parkinson's Disease and Amyotrophic Lateral Sclerosis

Project Summary
Parkinson’s disease (PD) and Amyotrophic Lateral Sclerosis (ALS) are irreversible and currently incurable
neurodegenerative diseases with more than 65,000 new cases in the USA each year. Their core motor symptoms
are respectively caused by dysfunction and death of dopaminergic neurons within the substantia nigra and motor
neurons in the cortex, brainstem, and spinal cord. However, non-cell-autonomous contributions to disease
progression are widely recognized and include cerebrovascular (CV) dysfunction. The CV is formed by several
highly specialized cell populations, including brain endothelial cells (BECs), mural cells, fibroblasts, and glia.
Given the CV’s critical role in regulating biomolecule transport into and out of the brain, blood flow, and responses
to physical or chemical stress, understanding the molecular underpinnings of early CV changes during PD and
ALS may be critical to develop disease-modifying treatments.
Prior work indicates that CV changes can occur during the progression of PD and ALS, including leakage of
the blood-brain barrier (BBB), angiogenesis, dysfunctional efflux activity, dysregulated blood flow, and increased
immune cell trafficking. However, findings from brain imaging (MRI) and histological analysis are not inclusive of
all CV functions nor able to identify transcriptional regulators, while studies using animal models are not
representative of sporadic human disease which accounts for ~90% of PD and ALS cases. In this proposal, I
will characterize cerebrovascular dysfunction during sporadic PD and ALS with cell type-specificity and
whole genome-resolution from post-mortem tissue, and will benchmark the degree to which this
dysfunction is recapitulated by iPSC-derived in vitro models. This work is grounded in recent application of
blood-vessel enrichment (BVE) and single nucleus RNA sequencing (snRNA-seq) approaches to profile gene
expression of CV cells, and the development of transcription factor overexpression-based differentiation of BECs
from induced pluripotent stem cells (iPSCs). In Aim 1A, I will conduct snRNA-seq on blood vessel enriched
substantia nigra from post-mortem PD patients and age-matched healthy controls, and will then validate cell
type-specific dysfunction using immunofluorescence and in situ hybridization studies. In Aim 1B, I will
differentiate BECs from PD patient iPSCs and age-matched healthy controls and then conduct snRNA-seq to
determine how post-mortem hallmarks of dysfunction are reflected in vitro. In Aim 2, I will take a similar approach
by conducting snRNA-seq on ALS patients blood vessel enriched motor cortex and iPSC-derived BECs
compared to healthy age-matched post-mortem tissue and iPSC controls.
By characterizing CV gene expression using cutting-edge single nucleus profiling of PD and ALS post-
mortem tissue and iPSC-derived models, this proposal will identity previously unrecognized mechanisms of CV
dysfunction and serve as a critical launchpad for future studies to test causality in disease processes and validate
therapeutic targets across in vivo and in vitro models.

Public health relevance
Project Narrative Parkinson’s disease (PD) and Amyotrophic Lateral Sclerosis (ALS) are irreversible neurodegenerative diseases with limited disease-modifying therapeutics. During the course of these diseases, cerebrovascular changes have been documented by brain imaging, histological, and transgenic mouse studies, however early changes in cerebrovascular gene expression during sporadic human disease with cell type-specificity and whole genome- resolution are not known; thus, the causal role of cerebrovascular dysfunction on disease progression is not established and represents an underexplored therapeutic target. The goals of this project are to characterize early cerebrovascular dysfunction using unbiased transcriptomic profiling of post-mortem brain tissue from PD and ALS patients, and establish whether iPSC-derived models of the cerebrovasculature mimic disease phenotype.